PRODUCTION OF VARIOUS STRENGTH OF INJECTABLE LMP744 FOR CLINICAL USE; POP: 02/14/2020 - 02/13/2021

The Contractor will manufacture injectable LMP744 at various strength under cGMP condition for clinical use including one base year and four (4) one-year options during the next five years.